Determining the mechanisms of spoken language processing delay for children with cochlear implants

Project Summary
While cochlear implants (CIs) have enabled children with profound hearing loss to hear via an electrical
signal, the speech signal they transmit is degraded in ways that hinder speech perception. These difficulties
with speech perception likely have downstream consequences on development, as children with CIs are more
likely to show delays in speech, language, and literacy abilities relative to peers with NH. However, it is unclear
how CI-specific limitations in speech perception contribute to observed delays in spoken language processing.
The long-term objective of this project is to better understand how the degraded CI signal impacts
spoken language development in children with CIs in order to design more targeted and efficacious
intervention for this population. The specific objective of the proposed research is to utilize psycholinguistic
methods to investigate how the spectrally degraded speech signal transmitted by CIs delays spoken word
recognition and the access of networks of semantically related words in the lexicon, which are both vital
components for efficient spoken language comprehension. Aim 1 will investigate the potential sources of
observed delays in spoken word recognition by children with CIs. Specifically, the proposed experiments will
determine whether perception of a spectrally degraded signal leads to expanded and less efficient
lexical competition or adoption of a general wait-and-see listening strategy. The applicant will use eye-
tracking to measure competition from similar-sounding words while children with CIs (Experiment 1) and
children with NH listening to noise-vocoded speech (Experiment 2) perceive spoken words. Experiment 3 will
use electroencephalography (EEG) to measure semantic processing of phonologically similar words during
spoken word recognition. Aim 2 will investigate the possible mechanisms underlying observed delays in use of
semantic context by children with CIs to facilitate spoken language processing. The team will determine
whether lexical access by children with CIs involves cascading activation from phonological to
semantic networks or instead occurs as a more serial process. Experiment 4 will use EEG to measure
how similar-sounding words and their semantic associates are activated during spoken word recognition.
Training goals focus on learning to use EEG methods for psycholinguistic research, manipulation of
speech stimuli, and advanced statistical analysis of time series data. In addition, training will foster skills
needed to independently carry out innovative and clinically applicable research by incorporating findings from
the field of cognitive neuroscience and collaborating with clinical faculty and local clinicians.
The findings from the proposed project will contribute to a more detailed understanding of the
mechanisms behind observed delays in spoken language processing by children with CIs. Processing
mechanisms yielding individual differences in spoken word recognition also have the potential to be targets of
speech-language intervention for children with CIs who are at-risk of falling behind in language development.

Public health relevance
Project Narrative Children with profound hearing loss who receive cochlear implants comprehend spoken language better than those without access to this electrical hearing, but these children are still at risk of significant speech and language delays. This project utilizes sophisticated psycholinguistic methods to investigate how limitations of the speech signal transmitted by the CI contribute to observed inefficiencies in spoken language processing by children with CIs. Understanding the mechanisms by which the degraded CI signal hinders spoken language processing will allow for development of more targeted interventions in spoken language comprehension for children with CIs.